Development of a Region-Specific JEM for Exposure Surveillance

Project Summary Occupational exposure surveillance is necessary for the identification of worker populations at risk of developing occupational disease and the prioritization of mitigation efforts but is largely absent from current US national occupational health surveillance systems. There is an urgent and unmet need for the development of surveillance methods and systems to facilitate the examination of occupational exposure trends in the US. The overall objective of the proposed study is to construct general-population job-exposure matrices (JEMs) for chemical hazards across industries in Michigan and Federal Region 5 and to assess exposure and overexposure trends and prevalence for single and mixed hazards. Aim 1 will involve the construction of these JEMs and the modeling of multiple indices of exposure as well as the trends in exposures over time across industries. Aim 2 will group these exposures according to shared adverse health effects and will quantify the potential for mixed exposures. Aim 3 will estimate the prevalence of exposures and overexposures across hazards and health effect groupings in Michigan and Region 5. The results of these aims will be used to target outreach, education, and interventions as part of an overarching occupational health surveillance program for Michigan operated through Michigan State University (MSU) and will be shared with the Michigan Occupational Safety and Health Administration (MIOSHA) to aid in the prioritization of industries for compliance activities. This research will span NORA sectors and be relevant to the Cancer, Reproductive, Cardiovascular and Other Disease Prevention, Immune, Infectious, and Dermal Disease Prevention, and Respiratory Health NORA cross-sectors. It will directly address NIOSH strategic and intermediate goals pertaining to exposure surveillance as well as providing an exposure assessment tool for future epidemiological studies supporting NIOSH goals relating to the characterization of relationships between exposures and adverse health outcomes. The project aligns with the NIOSH Research to Practice (r2P) approach, as the outcomes will be shared directly with MIOSHA and employer/employee groups with whom the MSU program has relationships in order to identify and reach at-risk worker groups for exposure mitigation. Through this project, Dr. Oliveri will complete a plan for career development that will involve a combination of mentorship from Drs. Kenneth Rosenman at MSU and Richard Neitzel at the University of Michigan School of Public Health (UMSPH), experiential learning, and formal coursework. This plan will add to Dr. Oliveri’s experience and capabilities regarding exposure analysis and JEM construction, occupational health surveillance, occupational epidemiology, and advanced statistical techniques. The MSU Division of Occupational and Environmental Medicine and UMSPH Departments of Environmental Health Sciences and Epidemiology will provide Dr. Oliveri with the resources and intellectual support necessary to complete the proposed career development and research activities.

Public health relevance
Project Narrative The continuing implementation and improvement of occupational health surveillance systems is integral to the prioritization and targeting of outreach, education, and compliance activities, as well as the advancement of knowledge concerning the relationships between work and disease. By compiling and leveraging compliance data collected by both Michigan OSHA and federal OSHA in Federal Region 5, as this study aims to do, an exposure databank and series of Job Exposure Matrices (JEMs) will be constructed that will provide invaluable and, before now, largely uncharacterized details concerning temporal trends in occupational exposures, the extent of mixed exposures, and the population-level prevalence of worker exposures in the Region. These insights will be utilized to identify those industries and worker populations in which high levels of exposure are the most prevalent for mitigation and to assign exposures in epidemiological studies through which links between exposures and health outcomes can be newly identified or further characterized, uses that together provide an opportunity for the primary prevention of occupational disease.